GPR6: A Circuit-Level Druggable Target in Cocaine Use Disorder

ABSTRACT
Cocaine use disorder (CUD) remains a significant threat to the health and welfare of millions of affected
individuals. Despite advances in understanding the neurobiology of CUD, the impact of chronic cocaine use on
the brain and the neuronal mechanisms underlying associated behavioral deficits are not fully understood,
representing untapped opportunities for therapeutic intervention. Cocaine induces potent rewarding effects
primarily through rapid dopamine (DA) release, with medium spiny neurons (MSNs) in the nucleus accumbens
(NAc) being particularly responsive to this DA surge. Using a bioinformatics-informed approach, we identified
high and selective expression of the G protein-coupled receptor (GPCR) GPR6 in MSNs. GPR6 is an orphan
GPCR which lacks verified endogenous agonist(s) and exhibit high constitutive activation of Gs signaling which
is proposed to regulate reward-specific behaviors. This proposal aims to address key cell-type and pathway-
specific questions by investigating: 1) GPR6 expression on D1R- vs. D2R-MSNs within CUD neurobiology, 2)
GPR6 status following intravenous self-administration (IVSA) of cocaine, and 3) the therapeutic potential of
GPR6 ligands in CUD treatment using IVSA models. Overall, elucidating GPR6 circuitry, behavior, and signaling
mechanisms in well-controlled conditions holds significant potential to inspire innovative approaches for CUD
medications. GPR6 is a unique and compelling target for medications development with minimal likelihood of
undesirable effects as only trace expression is observed in other tissues.

Public health relevance
PUBLIC HEALTH RELEVANCE Cocaine use disorder (CUD) is a global and personal public health issue in the United States, with no FDA- approved medications available to enhance treatment outcomes. We have identified the orphan G protein- coupled receptor GPR6 which is predominantly expressed in neurons of CUD neurocircuitry providing a unique and compelling target for therapeutic intervention. This project aims to elucidate the role of GPR6 in CUD neurobiological and behavioral dimensions.